Investigation of Electrolyte Homeostasis via Quantitative Proteomics

DESCRIPTION (provided by applicant): Electrolyte homeostasis is essential for life at the cellular level, in that, cells must respond to osmotic challenge to fend off changes in cellular water and ion content that could lead to rupture. On a larger scale, humans regulate blood pressure by maintaining an appropriate balance of sodium reabsorption and excretion in the kidney. Hypertension, a major health problem affecting more than 60 million Americans, is a result of a dysfunction in electrolyte homeostasis. Therefore, understanding mechanisms that control electrolyte homeostasis is important for human health. It is becoming increasingly clear that a core set of regulatory proteins senses and maintains electrolyte homeostasis. Our knowledge is lacking in how this is achieved at the molecular level. The molecular mechanisms of electrolyte homeostasis are of critical importance for both healthy and disease states in humans and thus must be understood in order unlock their therapeutic potential. We aim to understand the network of proteins and signaling mechanisms, mainly regulatory phosphorylation events, which connect mechanisms of cell volume control and blood pressure homeostasis. The red blood cell holds great potential as a model system to understand the fundamental elements critical for electrolyte homeostasis. We will use a quantitative proteomic approach to study networks of signaling proteins that regulate electrolyte flux in red blood cells. We will focus our studies on the K-Cl cotransporters as a representative direct mediator of electrolyte flux and the kinases Wnk1 and Wnk4 as critical signaling components of ion flux. These studies will provide new insight into the upstream regulation of Wnk function and downstream signaling events that control electrolyte homeostasis by identifying critical regulatory phosphorylation sites. To link these observations to the in vivo setting, we will use SILAC technology in the mouse red blood cell to quantify critical regulatory phosphorylation sites that respond to specific physiologic perturbation. The purpose of this study is to provide a fundamental understanding of the mechanisms that coordinate electrolyte homeostasis. Furthermore, we are seeking mechanistic links in blood pressure control and cell volume regulation in order to find new target points to treat diseases such as hypertension and sickle cell anemia.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this study is to provide a fundamental understanding of the mechanisms that coordinate electrolyte homeostasis. Hypertension, a major health problem affecting more than 60 million Americans, is a result of a dysfunction in electrolyte homeostasis. Therefore, understanding mechanisms that control electrolyte homeostasis is important for human health. The purpose of this study is to provide a fundamental understanding of the mechanisms that coordinate electrolyte homeostasis. Hypertension, a major health problem affecting more than 60 million Americans, is a result of a dysfunction in electrolyte homeostasis. Therefore, understanding mechanisms that control electrolyte homeostasis is important for human health. __SpecificAimsTextDelimiter__ Specific AIMS Electrolyte homeostasis is critical on the cellular and organismal level. All cells must respond to osmotic challenge to fend off changes in cellular water/ion content that could lead to lysis. Humans regulate blood pressure by maintaining an appropriate balance of sodium reabsorption and excretion in the kidney. It is becoming increasingly clear that these same pathways are linked by a core set of regulatory proteins that sense and maintain electrolyte homeostasis. Our knowledge is lacking of how this is achieved at the molecular level. The molecular mechanisms of electrolyte homeostasis are of critical importance for both healthy and disease states in humans and thus must be understood in order unlock their therapeutic potential. We aim to understand the network of proteins and signaling mechanisms, mainly regulatory phosphorylation events, which connect mechanisms of cell volume control and blood pressure homeostasis. We recently used quantitative proteomics to identify two phosphorylation sites that control K-Cl cotransporter (KCC) activation in response to cell swelling (1). KCC activity is increased in the red blood cells of patients with sickle cell anemia and thus understanding KCC regulation is critical. In addition, we linked the kinase Wnk1 to the KCC regulatory phosphorylation sites (1). Wnk1 is mutated in humans with inherited forms of high blood pressure and once again underscores the potential impact this signaling network has on human health (2). The red blood cell holds great potential as a model system to understand the fundamental elements critical for electrolyte homeostasis. These proteins and their corresponding signaling networks will be elucidated by targeting individual phosphoproteins as well as the intact phosphoproteome of the red blood cell. We will focus our studies on the K-Cl cotransporters as a representative direct mediator of electrolyte flux, the kinases Wnk1 and Wnk4 as critical signaling components of ion flux, and the link in their signaling pathways in the context of the red blood cell. We will address the following specific aims: Specific Aim 1: Identify the kinase that directly phosphorylates KCCs at the two sites that control activation in response to cell swelling. Recent advances in phosphopeptide profiling are revealing the phosphoproteome at a rapid pace (3). While sites of phosphorylation can now be rapidly identified, the corresponding kinase responsible is often not obvious from the identity of the site alone. To answer this question in an unbiased fashion we have devised and implemented a 177 member, serine/threonine kinase screen that can rapidly match a phosphorylation site with a partner kinase. A phosphoantibody is used to identify positive hits followed by validation via MS. Relative quantitation is achieved in a site specific manner with a heavy labeled synthetic peptide matching the phosphopeptide of interest. a. Identify candidate kinases with an in vitro 177 serine/threonine kinase screen. The kinase responsible for directly phosphorylating the two regulatory phosphorylation sites in the K-Cl family of cotransporters has not been identified. A recombinant KCC3 substrate will be generated and candidate kinases will be identified with the kinase screen. b. Validation of candidate KCC kinases with siRNA knockdown in cell culture. Candidate kinases will be targeted by knockdown with RNA interference in HEK cells stably expressing KCC3. The effect on phosphorylation will be examined with phosphoantibodies. Specific Aim 2. Identify the phosphorylation sites in Wnk1 and Wnk4 that respond to cell swelling. The Wnk kinases all appear to be specifically phosphorylated and at least some of these sites are phosphorylated in response to specific physiologic stimuli. We have developed a phosphopeptide enrichment strategy coupled to mass spectral identification of phosphorylation sites. In brief, we purify epitope-tagged kinase expressed in human embryonic kidney cells, digest the protein with trypsin, purify phosphopeptides via titanium dioxide (TiO2) and identify specific phosphopeptides by mass spectrometry. A SILAC based strategy is then used to study phosphorylation dynamics. SILAC allows direct comparison and quantitation of phosphorylation events on proteins exposed to different experimental conditions. a. Phosphorylation dynamics in Wnk1 and Wnk4 in response to cell swelling. Using the above approaches, we will comprehensively identify phosphorylation sites within Wnk1 and Wnk4 which respond to cell swelling. Wnk kinases show altered phosphorylation and activity in response to osmotic stress; the sites that are responsive are unknown. b. Phosphorylation of Wnk1 in complex with SPAK. The downstream path from Wnk1 and Wnk4 is believed to occur through another serine-threonine kinase, OSR1/SPAK. Wnk1 and Wnk4 have been shown to physically interact with OSR1/SPAK. We will purify Wnk1/SPAK complexes from HEK cells by immunoprecipitation and determine whether their phosphorylation states are altered when these two molecules are in complex under isotonic and hypotonic conditions. A SILAC strategy will be employed in these studies as well. Comparing alteration in these two states will provide clues as to which sites are important in the response to cell swelling. c. Phosphorylation of Wnk4 and Wnk1 when they are co-expressed. Wnk1, Wnk4, and OSR1/SPAK are expressed in the same renal epithelia and in red blood cells. Wnk1 is believed to regulate the activity of Wnk4. Using a SILAC strategy, we will examine phosphorylation dynamics in both kinases that result from their co-expression in HEK cells. Specific Aim 3. Establish a SILAC mouse model to directly study phosphorylation dynamics in the red blood cell. Cellular signaling networks exist in an integrated scaffold that serves to control most aspects of cell physiology. The ability to study individual systems and proteins in their native framework is highly desirable to elucidate their biological functions. Recent advances have brought SILAC based quantitative proteomics to bear on whole animal physiology (4). Our aim is to use the network of red blood cell phosphoproteins as a gateway to study phosphorylation dynamics in cell volume control. We will use RBCs from SILAC labeled mice as a reference proteome to study changes in protein phosphorylation in the red blood cell. We aim to use this innovative approach to identify, in a native tissue, key phosphorylation sites in proteins that control cell volume. Specifically we will develop the SILAC mouse technology to study the connection between Wnk kinase regulation and cell volume control. We will use this in vivo approach to study and validate the novel signaling mechanisms reveled in aims 1 and 2. a. Development of a SILAC mouse model for red blood cell phosphoproteomics. We will develop approaches to fractionate the red blood cell phosphoproteome to increase depth of proteome coverage. Since SILAC adds an additional layer of complexity, this aim will be carried out with the SIALC labeled red blood cells. We will also develop targeted enrichment strategies to study Wnk kinases and the KCC kinase identified in aim 1. b. Validation of the SILAC mouse model. We will target two highly abundant phosphoproteins in the red blood cell membrane to validate the SILAC approach to study phosphorylation dynamics. Dematin and adducin are actin-binding proteins associated with the RBC membrane architecture. Double knock-out mice lacking beta adducin and the headpiece domain of dematin result in altered erythrocyte morphology, increased membrane instability, and severe hemolysis (5). Targeted deletion of these two critical membrane proteins is expected to disrupt normal phosphorylation in the RBC membrane architecture. We will use a SILAC approach to identify and quantify the effect of the double knock out on the red blood cell membrane phosphoproteome. We will identify phosphorylation sites that are critical to red blood cell membrane stability. c. Identification of phosphorylation dynamics in signaling pathways that control cell volume. We will systematically target the Wnk kinases, the KCl cotransporters, and the kinase(s) identified in aim 1 to identify phosphorylation sites in these proteins that respond to cell swelling. These studies will validate our previous studies carried out in cell culture and also verify the physiological relevance of the observations made in aim 2. This SILAC mouse approach holds great potential to reveal novel and physiologically relevant signaling mechanisms in electrolyte homeostasis.